Administrative Core

(CORE A: ADMINISTRATIVE CORE)
PROJECT SUMMARY
This Administrative Core will provide oversight and management of the Intellectual and Developmental Disabilities
Research Center at the Children’s Hospital of Philadelphia (CHOP) and the University of Pennsylvania (Penn).
The center has three specific aims. First, we will lead an innovative, translational research agenda by supporting
cores that continually evolve to provide cutting-edge technologies and meet the needs of center members. The
center also supports a new research project that uses most of these cores to determine if
magnetoencephalography (MEG) can be used to predict general cognitive ability and language-specific ability in
children with a genetic risk for intellectual disability. Second, we will lead a career development initiative that
supports multidisciplinary training. Third, we will promote interactions and collaboration, advocate for IDD
research and its growth at CHOP/Penn and beyond, and we will ensure that advances in IDD research are rapidly
disseminated to a wide variety of scientific and lay audiences with a focus on families of children with IDDs.
The Administrative Core oversees management, strategy and vision for the IDDRC. It will: (1) Provide oversight
of the cores including review and approval of new users, review of utilization, and survey user satisfaction; (2)
Provide oversight of the research project, including regular progress meetings; (3) Provide oversight of core
budget and monitoring their of cost-effectiveness; (4) Manage all training related activities, including organizing
seminar series; (5) Maintain websites for the IDDRC and our training programs; (6) Coordinate meetings with
internal, external, and patient advisory groups; (7) Manage all communication with NICHD; (8) Foster
collaborations with other IDDRCs across the network; (9) Lead institutional, regional, and national advocacy; (10)
Disseminate research findings to academic and community/family organizations and stakeholders; and (11)
Organize activities that encourage networking and collaboration between cores, among center members, and
with other centers and resources at CHOP/Penn.
The center has three guiding principles. First, we seek to foster community, to encourage collaborative, inter-
disciplinary research and to attract the next generation of scientists to the field. Second, solicit advice from our
advisory committees to help the center continually evolve so that we meet the needs of our users and our
community of constituents. Finally, we emphasize support of innovative, translational research that will define
the etiology/pathophysiology of IDDs and lead to new interventions for children and adults with
neurodevelopmental disabilities. Collectively, our activities are sharply focused on supporting research that has
the potential to greatly impact the lives of those with an IDD.